INFLUENCE OF POSTMENOPAUSAL ESTROGEN REPLACEMENT ON GROWTH HORMONE

We will test if estrogen replacement in postmenopausal women increases the rebound release of GH. Two subjects have completed the study. We will evaluate estrogen's effects on ten women.